Optimizing anti-wild-type IDH1 therapy in pancreatic cancer

Pancreatic ductal adenocarcinoma (PDAC) is the most deadly of the common cancers, with limited treatment
options. Chemotherapy is marginally effective, while targeted or immunologic agents have little benefit. We
recently showed that wild-type IDH1 (wtIDH1) is required for PDAC cells to survive their harsh and nutrient-
limited microenvironment (TME). The cytosolic enzyme, IDH1, converts isocitrate to α-ketoglutarate (αKG), using
NADP+ as a cofactor. In the setting of nutrient scarcity, the reaction products (NADPH and αKG) help neutralize
free radicals and boost mitochondrial function, respectively. Under TME-associated conditions, we discovered
that allosteric IDH1 inhibitors, designed and approved to selectively treat mutant-IDH1 tumors, actually target
the wtIDH1 enzyme. Tumors have very low Mg2+ levels, which permits drugs like FDA-approved ivosidenib to
outcompete the cation in the allosteric pocket, leading to increased efficacy against wtIDH1 PDAC across tumor
models (see Nature Cancer, 2022). While anti-wtIDH1 therapy is promising, especially in combination with
chemotherapy, in this proposal we identify practical, safe, and chemo-sparing treatments that optimize anti-
wtIDH1 therapy based on our recently acquired insights. Specifically, strategies (pharmacologic or dietary) that
further enhance PDAC reliance on antioxidant defense and mitochondrial metabolism for survival are particularly
effective. Relevant to this work, olaparib is the only FDA-approved targeted treatment of PDAC. The drug inhibits
PARP1-mediated DNA repair and is indicated for BRCA-mutant PDAC (<10% of cases), which all exhibit
homologous recombination (HR) deficiency. PARP blockade shifts metabolism towards oxidative
phosphorylation. A ketogenic diet also reprograms metabolism in this direction by reducing glucose availability.
In Aim 1, we pair wild-type IDH1 (ivosidenib) and PARP1inhibitors (olaparib) in both HR deficient and proficient
PDAC using GEMM and PDX models. We will show for the first time that wtIDH1 blockade directly inhibits PARP
(through increased NADP+) and induces a BRCA-like phenotype (through decreased αKG and histone
hypermethylation), resulting in strong synergy between drugs, even in HR proficient PDAC. The intent of this
combination is to expand the indications for olaparib to the majority of PDAC. In Aim 2, we will demonstrate that
anti-wtIDH1 therapy is potentiated when combined with a ketogenic diet. The two treatments synergize
mechanistically, as a ketogenic diet drives the production of free radicals and shifts metabolism towards oxidative
phosphorylation, which magnifies PDAC’s need for wtIDH1. We also show that both therapies reduce histone
acetylation: low glucose from a ketogenic diet depletes a carbon source, while reduced TCA cycle activity after
wtIDH1 inhibition also affects acetyl CoA pools. In Aim 3, we will analyze PDAC patient samples from an ongoing
clinical trial (NCT05209074) for ivosidenib activity against wtIDH1, compared to control samples. Metabolic and
DNA repair changes will be assessed. We will also compare tumoral Mg2+ levels to serum. These aims will inform
future studies and trials seeking to optimize anti-IDH1-based therapies in patients.

Public health relevance
Recent work by our group established that ivosidenib is a potent wild-type IDH1 inhibitor with strong anti- pancreatic cancer effects under tumor-associated conditions, like low magnesium and glucose. In this proposal, we seek to optimize this treatment even further by nominating therapeutic partners that induce free radicals or shift metabolism towards oxidative phosphorylation, like a ketogenic diet or PARP inhibition. Further, we analyze patient samples to show that allosteric IDH1 inhibitors are indeed active against the wild-type enzyme, paving the way for future translational studies testing these combinatorial approaches in patients.